Principles in Pulmonary Research

Project Summary
The Washington University Program in Principles of Pulmonary Research provides multidisciplinary training for
predoctoral and postdoctoral scholars committed to a career in pulmonary research. The aim of the Program is
to prepare a diverse group of individuals for a career in academic pulmonary medicine through rigorous research
training to address problems in lung biology and disease. The predoctoral portion of the Program engages PhD
and MD-PhD students in the graduate school by direct connection to experts in lung biology. The postdoctoral
portion of the Program enables MD and MD-PhD physicians who are training in clinical pulmonary and critical
care medicine to learn state-of-the-art scientific research, in concert with PhD trainees from a basic science
background. The Program funds seven postdoctoral and five predoctoral trainees for 2-3 years of support before
they transition to additional career development awards. Trainees and mentors are selected to represent a
diversity of interests, skills, and experiences. The Program and its trainees are closely monitored through a multi-
director (PD) approach and five Committees (Program Review, Diversity Recruitment, Wellness and Mentoring,
Internal Advisory, and External Advisory). The success of the program is driven by an individualized training
approach with frequent points of contact between the MPIs, trainees, and preceptors, toward a set of trainee
core competencies. Progress is monitored by bidirectional evaluations between trainees and preceptors, with
input from advisory committees. Research skills are developed in one of three interdisciplinary research tracks:
two basic-translational pillars (Immunology-Host Defense, and Molecular-Cell Biology) and a Clinical-
Translational Sciences pillar. The clinical pillar extends these basic science strategies to human subject research.
The approach provides a multidisciplinary, collaborative, and synergistic plan for research training by bringing
together diverse expertise. For all trainee activities within this structure, there is a carefully constructed mentoring
process that includes competency-based milestones for trainee presentation, publication, and grant application.
To achieve these goals, predoctoral and postdoctoral training efforts are integrated at a weekly Pulmonary
Research Conference. The Conference is the hub for input from an overall Program Review Committee (that
includes the PDs and their advisors) and a project-specific Advisory and Development Committee (that includes
the trainee’s mentors and collaborators). Trainees also receive input via individual lab and group meetings and
additional research conferences. The research-intensive experience is supplemented through graduate
coursework (including a Master of Science) to build specialized skills and mandatory training in the Responsible
Conduct of Research. A set of workshops and retreats stress communication skills, grantsmanship, mentoring,
teaching skills, DEI training, and wellness. Together, these mechanisms serve to ensure high-level
multidisciplinary trainee experiences and performance in previous and present cycles of this longstanding, highly
successful Program that has positioned numerous leaders in lung disease across the United States.

Public health relevance
Project Narrative Respiratory disease represents a major health care problem. Indeed, influenza and pneumonia, as well as chronic respiratory (lung) diseases, are among the top ten leading causes of death in the U.S. population. The purpose of our pulmonary research training program is to develop new leaders and innovators to drive research and development in the field of lung biology and disease and thereby solve this problem.